Epidemiology of Age-related Dementia, Mild Cognitive Impairment and Brain Pathology in a Multiethnic Cohort of Oldest-Old

Project Summary
The Life After 90 Study is a lifecourse cohort study of Alzheimer's disease and related dementia (ADRD),
cerebropathology, and cognitive aging in diverse oldest-old individuals. Recently launched, and still enrolling, LA90 is the
largest, most ethnic/racially diverse cohort study of the oldest-old with prospective clinical and lifestyle data from as early
as 1960/70s. In Cycle 1, we enrolled 908 individuals aged 90+ (mean age 92.6, range 90-105) from a range of enthoracial
backgrounds (22% Black, 24% Asian, 20% Latino, 28% White, 1% Other, 6% Multi-Race). Participants are seen every 6
months with an average of 2.9 research visits per person to date. All visits include an extensive neuropsychology battery
and clinical exam, research interview including measures of lifecourse social experience, brain donation program, and,
among a subset, PET and MRI imaging. The LA90 cohort encompasses an array of life experiences, 17% were born
outside of the US, 35% have <high school education, 40% are multilingual or learned English as a second language, and
24% born in southern US. Our initial findings suggest that there is vast heterogeneity and complexity in the trajectory of
cognitive change, brain pathologies, and neuroimaging markers of brain status in the 10th and 11th decade of life. In this
competitive renewal application, we extend our science to investigate blood-based biomarkers for ADRD in oldest-old
using the ATN framework (amyloid, tau, neurodegeneration), expand our brain donation-based pathology, and enroll an
additional 500 ethnic/racially diverse participants. Additionally, we will leverage decades of antecedent health data
available to identify early and midlife markers for oldest-old cognitive `SuperAgers'. Our aims are: Aim 1. Enroll 500
additional oldest-old individuals to determine more precise age-specific, race-specific, and sex- specific incident rates of
cognitive impairment, ADRD, and cognitive decline over 8 years. Aim 2: Determine the contribution of neuroimaging
markers of amyloid, vascular injury, and brain atrophy on cognitive decline and ADRD in diverse oldest-old. Aim 3:
Continue enrollment into brain donation and characterize the contribution of brain pathologies on cognitive decline, and
ADRD in the oldest-old. Aim 4: Collect and quantify blood-based biomarkers consistent with the ATN framework and
evaluate their contribution to ADRD and cognitive impairment in diverse oldest-old individuals. Aim 5: In a diverse
cohort of oldest-old, identify and understand lifecourse predictors of cognitive `SuperAgers'. Renewal of LA90 will create
an unprecedented scientific resource for studying ADRD and cognitive outcomes in a diverse cohort of oldest-old
individuals, a group representing the rapid diversification of this population.

Public health relevance
Project Narrative LifeAfter90 is a newly launched cohort study of diverse individuals aged 90+ which has successfully enrolled and followed 908 research participants in 36 months. The continuation of LifeAFter90 will provide not only new information on dementia, and brain neuropathology but will also reveal early life contributions and risk factors for both cognitive `Super-Agers” and cognitive impairment. Renewal of LA90 will create an unprecedented scientific resource for studying Alzheimer's disease and cognitive outcomes in a diverse cohort of oldest-old individuals, a group representing the rapid diversification of this population.